Short-Term Institutional Research Training Grant

This multifaceted S/T research training program in year 37 at The University of Arizona (UA) introduces, trains and
nurtures diverse inquiring medical students in health-related biomedical research; and further, stimulates subsequent
intensive and extensive research experiences. Building on the high level of student/faculty participation and esprit-de-
corps already generated and the outstanding record of trainee productivity (presentations, publications, awards, and
advanced research), 26 (3 month)-39 (2 month) medical students annually will engage in F/T summer/vacation
laboratory/clinical investigations with an NHLBI emphasis, fully integrated into an innovative Curriculum on Medical
Ignorance. CMI features an intensive Summer Institute (SIMI) and wide variety of year-round enrichment activities open
to all students (seminars/ workshops, clinical correlations, Failure/Pondering Rounds, journal clubs, skill practice,
Visiting Professors, career advising, and advanced extracurricular research through a popular student-initiated Research
Distinction Track). An expanding interactive online "Translating Translation" presence with an evolving Precision
Medicine theme, featured on our unique multimedia Virtual Clinical Research Center/Questionarium web-based mobile
accessible platform/grid, focuses on examples, scenarios, and steps in the translation process. CMI aims to foster attitudes
and skills to recognize and deal with the vast shifting world of medical ignorance ["what we know we don't know (current
research), don't know we don't know (future discovery), and think we know but don't (error)"] from molecular to clinical
and community medicine. Questioning, critical/creative thinking, communication, team-building, role-modeling, and
leadership skills are specifically cultivated to forge a mentoring chain reaction at the local, national, and international
level and throughout a diverse NIH-funded multilevel research pipeline continuum. Overseen by an experienced
multidisciplinary administrative team and paralleling UA's expanding research strengths, students choose from a
spectrum of in vivo, in vitro, in situ, in silico, and modeling approaches to the cardiovascular (CV) system and disorders
(cardiac contractility, development, hypertrophy, microcirculation, endothelial biology, electrophysiology, oxygenation,
heart failure, resuscitation, CV genomics/proteomics, CV prosthetics, arterial/venous disease, lymphology); pulmonology
(asthma, cystic fibrosis, pulmonary hypertension, sleep apnea, organogenesis); and cell-based science/therapy; with
cross-cutting themes in bioengineering/multimodal imaging; drug/device discovery R&D; and other topics of specific
interest to student researchers and spanning translational steps from bench to bedside to clinical practice and population
health. Based on a 37-year track record reflected in followup surveys, we anticipate cultivating an enlarging number of
scientific physicians who understand and contribute to the research enterprise and a growing cadre of physician-scientist
leaders to replenish the dwindling supply of translational researchers. Detailed S/T and L/T formative/summative
program/participant evaluation with database registry, individual development plans, and career portfolios will document
efficacy.

Public health relevance
PROJECT NARRATIVE Based on a 35-year track record, reflected in our latest Medical Student Research Program followup, we anticipate cultivating a large number of diverse inquiring scientific physicians who understand and can contribute to the research enterprise (emphasizing cardiovascular, lung, and blood disorders, mechanisms, evaluation, and therapy), including a growing cadre of physician-scientist leaders to replenish the dwindling numbers of translational medical researchers. In this way, we will contribute to the concerted effort of NIH and NHLBI to build the diverse enlightened medical research teams of the future, to provide the latest in personalized care and precision medicine, and thereby to expedite the translation of scientific advances from “bench to bedside to diverse community”.